Resource Core - Integrative Systems Core (ISC)

ISC Summary/Abstract:
The fundamental concepts underlying the Integrative Systems Core (ISC) are that age-related alterations in mobility and balance develop subtly, prior to overt clinical problems, and are due to multi-system interacting changes. The ISC provides state-of-the-art multidisciplinary expertise on age-related changes in mobility and the systems controlling mobility via collaborating laboratories encompassing 1) whole-body movement and balance, 2) nervous system structure, function, and energetics; 3) musculoskeletal structure, function and energetics, and 4) cardiopulmonary function. The ISC coordinates the resources among these laboratories to provide investigators with equipment, techniques and expertise and promote collaborative opportunities.
During the fourth cycle, the ISC supported 5 pilot exploratory studies (PES), 1 developmental project (DPs), 5 REC trainees (2 Scholars), and over 50 externally funded projects, all of which involved collaboration with other Pepper Cores, other Pitt Centers, and/or other institutions. In this renewal, the ISC will support 2 PES and 2 DPs in collaboration with other Pepper Cores.
Our specific aims are:
1. Provide cutting-edge resources and expertise to concurrently study both whole-body, as well as multiple systems and physiologic mechanisms affecting mobility and balance during aging, both during study planning as well as during implementation and analysis.
2. Develop and test novel techniques and approaches, including liquid biopsy, to address gaps and needs for multi-system evaluations of mobility and balance.
3. Support the training mission of the Pitt OAIC by educating and supporting the work of Pepper trainees through workgroups, seminars, “field trips” and active involvement in trainee research projects.
4. Support the preparation of new proposals for independent funding and support the implementation of independently funded awards.
5. Collaborate with other cores and Centers in and outside Pitt on OAIC-related activities.
6. Continuously monitor, evaluate and communicate about Core activities both within and among Core laboratory leaders, as well as with other Pepper Cores, Pepper leadership and NIA.
The ISC has formed the heart of the Pitt OAIC since its inception and has been instrumental in creating and disseminating new knowledge and new approaches to prevent and treat age- related problems with mobility and balance. In our proposed fifth cycle, we are eager to break new ground, provide new insights, create a new generation of well-versed investigators and ultimately, prolong independence in older adults.